TREATMENT OF UREA CYCLE DISORDERS AND RELATED DISEASES

The purpose of this project is to evaluate new treatment modalities for this group of diseases. A number of the medications used are still available on a research basis only.